Cortical microcircuit of performance monitoring: bridging multiscale neuronal activity and electrophysiological signatures in nonhuman primates

Project Summary
The error-related negativity (ERN) is a basic measure of RDoC because it indexes core functions of executive
control. Since its discovery, studies have shown that the ERN is a biomarker of psychiatric disorders, such as
ADHD, OCD, schizophrenia, and anxiety. However, the utility of the ERN as a biomarker depends on our
understanding of how it is generated at the cellular- and circuit-level. Different studies have reported the ERN to
be generated by medial frontal areas including anterior cingulate cortex (ACC) and the dorsomedial frontal cortex
(DMFC). However, the cortical mechanisms signaling error and conflict remain elusive. Therefore, to move
research and clinical translation forward, two critical barriers must be overcome: a) the need for a mechanistic
understanding of the cortical circuitry in error/conflict signaling, and b) the establishment of a theoretical
framework to translate microcircuit signaling into scalp potentials. In this proposal, I will overcome these barriers
by implementing a novel method, which incorporates anatomical information and connectivity of the area, to infer
the contributions of distinct neurons to the ERN and employ EEG forward modeling to translate their contributions
into microscopic signals. I hypothesize that the spiking activity and local field potentials (LFP) obtained from
laminar recordings can be used to predict the contributions of distinct populations of neurons to the EEG signals.
The primary research goal of this proposal is to determine the cortical mechanisms in DMFC that give rise to
the ERN and elucidate the contribution of ACC to its EEG signatures. The primary training goal is to master
the literature on performance monitoring and medial frontal lobe and gain expertise in cutting-edge computational
neuroscience methods. In Aim 1, I will elucidate the neuronal generators of the ERN in DMFC employing an
extended version of the generalized laminar population analysis (gLPAextended ). In contrast to the original method,
I will incorporate the distribution of cells obtained from laminar recordings and anatomical studies in macaque
monkeys, the connectivity of a microcircuit model for agranular frontal cortex, and the contribution of nonlinear
dendritic mechanisms present on neocortical pyramidal cells. In Aim 2, I will predict the EEG evoked by the
activity of cortical current dipoles in DMFC, obtained in Aim 1, employing EEG forward modeling. Then, I will
estimate the neuronal sources in ACC that give rise to the ERN by combining inverse methods and nonlinear
filtering techniques28 after subtracting the DMFC-related EEG from the recorded EEG signals. Using these ACC
current dipoles estimates and gLPAextended predictions for the ERN, I will assess the contribution of pyramidal
cells in ACC to the ERN. The outcomes of this proposal will provide circuit-level insights into brain disorders by
translating changes in the ERN into changes in microcircuit processing. The combined mentorship of my
sponsors, Dr. Riera and Dr. Schall, will guarantee the fulfillment of the research and training goals of this
proposal.

Public health relevance
Project Narrative The goal of this research proposal is to elucidate the neuronal genesis of the ERN, an event-related potential index of cognitive control and performance monitoring. The knowledge gained and the biophysically plausible models developed will have significant implications on our understanding of the underlying intricacies of neurological and psychiatric disorders such as ADHD, OCD and schizophrenia. They will allow us to have more insights into how the brain disorders affect the brain at the circuit level by translating changes in the ERN into changes in the microcircuit processing.